Algorithms for MR and OCT-based Architectonic and Laminar Segmentation

? DESCRIPTION (provided by applicant): The human brain is made up of an array of functionally and structurally defined regions. Localizing these regions is critical for early diagnosis of an array of diseases such as Alzheimer's disease (AD), as well as for neuroscientific research aimed at understanding the brain's functional and structural properties and clinical intervention in drug-resistant depression. Unfortunately, direct visualization of the laminar properties that are one of the defining characteristics of cortical areas is beyond current imaging technology, except in specialized cases that represent a small fraction of the entire cortex. In this project we propose to develop tools for segmenting cortical areas and laminar boundaries using ultra-high resolution ex vivo MRI and optical coherence tomography (OCT), then to make in vivo inferences via probabilistic modeling. This will allow us to develop and distribute tools that should permit automated areal and laminar localization, facilitating an array of clinical and neuroscientific research. The proposed analysis stream holds the promise of automatically deriving new laminar and area-specific morphometric measures, a critical advance in our goal of detecting neurodegenerative disorders early in their course, when therapeutic intervention is still possible, as well as for guiding disease treatment and staging in individual patients suffering from diseases such as depression or multiple sclerosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance automated segmentation of cortical areas and laminar boundaries will enable new and more specific types of analysis of neuroimaging data. In particular, the ability to probe laminar properties of specific cortical areas may provide significnt advances in developmental disorders such as autism, schizophrenia and dyslexia. The clinical relevance of the tools will be tested in three separate studies - in AD to determine the extent to which the measures can significantly increase the power of clinical trials, in depression to quantify whether the variability in treatment outcome of individual subjects can be reduced by using predicted architectonic information, and in multiple sclerosis, in which new evidence points to the importance of localizing the laminar identity of cortical lesions for improved diseas staging and for understanding its neurobiological basis.